National Center for Engagement in Diabetes Research

The overall goal of the National Center for Engagement in Diabetes Research: National CEDER is to strengthen the engagement of all communities in T2D research across the U.S. Our national reach is amplified through an expansive partnership of 18 academic institutions, including schools of public health and schools of medicine; and 10 regional and national community based organizations reaching communities impacted by T2D across the U.S. National CEDER, which comprises three synergistic cores, including an Administrative Core, Community & Collaboration Engagement Studio Core, and Research Consultation Services Core, aims to: 1. Strengthen established community-engaged, multi-sectoral regional partnerships to create a centralized, national network infrastructure designed to foster engagement in T2D research; 2. Accelerate engagement of all communities through a partnership hub model and integrated health frameworks that will inform T2D research priorities and methods; 3. Use community engagement, implementation science, adaptation frameworks, and other frameworks to improve uptake of research principles, methods and engagement strategies in T2D research through a robust studio and consultancy model rooted in bi-directional capacity building and co-leadership between community, healthcare, municipal, and research partners; and 4. Collaborate with researchers across disciplines and multi-sector groups to synthesize and disseminate best practices and lessons learned in advancing sustainable and replicable community engagement across the T2D research spectrum. National CEDER efforts will foster community-led and -informed T2D research for all populations by integrating community engagement across the research spectrum.

Public health relevance
Project Narrative: Overall The overall goal of the National Center for Engagement in Diabetes Equity Research: National CEDER is to strengthen the engagement of communities and individuals from diverse backgrounds and sectors in type 2 diabetes (T2D) research across the research spectrum and the United States. National CEDER will achieve this goal by 1) creating a centralized, national network infrastructure, 2) creating a partnership hub model that will inform T2D research priorities and methods, 3) developing a robust studio and consultancy model rooted in bi- directional capacity building and co-leadership, and 4) collaborating to disseminate best practices and lessons learned. National CEDER is an expansive partnership consisting of 18 schools of public health, schools of medicine, and minority-serving institutions; and 10 regional and national community based organizations reaching diverse African American, Latinx, Asian American, Native Hawaiian, Pacific Islander, and American Indian/Alaska Native communities, geographic areas, and communities facing historical marginalization.